Administrative Core

SUMMARY/ABSTRACT
The Administrative Core will execute the administrative, coordination, data sharing, and evaluation functions of
the Emory Lung Cancer SPORE to ensure that the research projects, cores and pilot projects of the Career
Enhancement Program (CEP) and Developmental Research Program (DRP) perform at their best levels. The
Administrative Core will play a pivotal role in monitoring progress, overseeing the change in direction of any
under-performing projects, and replacing them with new translational projects as needed.
To achieve its goals, the Core will perform the following administrative functions: (1) Provide necessary
resources and fiscal oversight/accounting; (2) Acquire and allocate institutional matching funds to facilitate
clinical trials and pilot projects; (3) Administer the CEP and DRP programs; (4) Prepare yearly non-competing
progress reports; (5) Ensure the ethical design and conduct of the proposed clinical trials in Projects 1 and 2
and the ethics companion study associated with Project 1.
The Core will also undertake the following coordination functions: (1) Arrange and coordinate monthly
SPORE investigators meetings, and the annual retreat; (2) Arrange travel to SPORE-related investigator
workshops & NCI Translational Science meeting; (3) Plan and facilitate annual meetings of the Internal and
External Advisory Boards; (4) Plan and facilitate monthly Executive Committee Meetings; (5) Provide and
coordinate SPORE-SPORE and SPORE-NCI interfaces; (6) Coordinate to assure the compliance of all
research projects with NCI, FDA and other federal, local and institutional regulations; (7) Engage patient
advocates to integrate a patient perspective.
Lastly, the Core will perform the following planning and evaluation functions: (1) Regular monitoring and
assessment of research progress; (2) Remediation or replacement of under-performing projects; (3)
Identification of new translational opportunities
The Core is fully dedicated to overseeing the conduct of the Lung Cancer SPORE program, and providing
organization and resources for the entire program, enabling it to fulfill its objectives to rapidly translate basic
science discoveries into clinical applications to benefit lung cancer patients.

Public health relevance
NARRATIVE The Administrative Core provides centralized functions for the Emory University Lung Cancer SPORE program to administer, coordinate, and oversee all meetings, budgets, financial and scientific reports, data management and sharing, project planning and evaluation, identification of new translational opportunities, problem solving, daily operations, and ethical conduct of the SPORE clinical studies. The Core will also provide support and administration for Developmental Research and Career Enhancement Programs, and coordination of the Executive Committee and Internal/External Advisory Boards. Core personnel will collaborate with NCI SPORE officials and with the members of other lung cancer SPORE programs nationally.